Investigating mechanisms mediating enhanced THC reinforcement by nicotine

Project Summary/Abstract
Polysubstance use (PSU) is extremely common, with the majority of substance use treatment seekers reporting
the use of multiple substances. Not only is the prevalence of PSU high, but the consequences of PSU are also
thought to be worse than for individuals who use single substances. One of the most common substances to be
used with any other drug of abuse is nicotine. Marijuana and nicotine co-use is particularly common, with higher
overall incidence of marijuana use in the general population and up to 80% of marijuana users reporting that
they also use nicotine. Recent epidemiological studies indicate that the co-use of nicotine with THC containing
products is increasing and those that use both drugs at the same time have worse overall outcomes than those
individuals that consume both, but on separate occasions. Thus, there is a need to increase our understanding
of the neural mechanisms affected by interactions between nicotine and THC. In ongoing studies, we have
developed procedures for understanding how nicotine influences intravenous THC self-administration in rats.
We have found that nicotine acutely and reversibly enhances the amount of THC self-administered, and in
concurrent choice procedures have found that nicotine availability enhances acquisition of THC self-
administration and leads to preference for THC over nicotine. In the present proposal we aim to determine the
mechanisms by which nicotine enhances the reinforcing properties of THC and the consequences of concurrent
nicotine and THC self-administration on the function of dopamine (DA) neurons in the ventral tegmental area
(VTA). In aim 1 we will use dual-color fiber photometry in the VTA and nucleus accumbens shell (NAc shell) to
determine the effects of nicotine on THC-induced DA neuron activity and DA release. In aim 2, we will use the
concurrent choice procedure to determine if nicotine-enhanced THC self-administration is mediated via actions
at α7 and/or β2/4 subunit containing nicotinic acetylcholine receptors (NAchRs) using specific antagonists. We
will further determine if either antagonist affects nicotine-THC mediated changes in DA neuron activity or DA
release. Finally, in aim 3, we will use a novel method for performing cell-type specific, mass spectrometry-based,
proteomic and phosphoproteomic analysis to determine the effects of nicotine-THC self-administration on DA
neuron function relative to either substance alone. Proximity labeling of proteins in DA neurons will be
accomplished through Cre-dependent viral expression of the APEX construct in TH-Cre rats. At the conclusion
of the proposed experiments, we will have determined: 1) if nicotine enhances the reinforcing effects of THC
through promotion of increased DA neuron activity and DA release in the NAc shell, 2) which NAchRs are
responsible for the enhanced reinforcement, and 3) what are the protein signaling consequences of co-self-
administration of the two substances on DA neuron function.

Public health relevance
Project Narrative Polysubstance use is a very common phenomenon that is generally thought to lead to worse outcomes than use of single substances. However, very little preclinical research has investigated polysubstance use, leading to a gap in our fundamental knowledge of how combinations of drugs may produce differential outcomes relative to single drug exposure. Thus, this project will use an established model of co-use of nicotine and THC, two of the most commonly co-used substances, to investigate neural mechanisms by which the two drugs interact to produce changes in dopamine neuron function and enhanced THC reinforcement.